Measuring the Longitudinal Relationshipsbetween Obesity, Weight Management Intervention, and Medical Expenditure

The prevalence of obesity among adults is stabilizing after decades of unrelenting increases and about
68% of Veterans are considered either overweight or obese. Obesity is the second leading cause of
preventable deaths in the US and is associated with a wide range of diseases, such as hypertension, type 2
diabetes mellitus, coronary heart disease, and osteoarthritis. These clinical risks lead obese patients to incur
disproportionately high health expenditures. In 2008, annual health expenditures attributable to obesity were
estimated to be $147 billion, concentrated among morbidly obese patients. In 2013, 28.2% of overall health
expenditures for adults was incurred for obesity-associated care.
Currently, three types of weight management interventions are available to overweight and obese VA
patients: behavioral lifestyle counseling, pharmacotherapy and bariatric surgery. The most widely used of
these interventions is behavioral counseling through the MOVE! program. Despite the widespread adoption of
MOVE! as a first line treatment for obesity in VA, MOVE! participation has been associated with modest short-
term weight loss and evidence is absent regarding the clinical and economic effectiveness of MOVE! beyond a
12-month follow-up. No prior VA studies have examined the natural history of weight gain, long-term
expenditures of normal weight, overweight and obese Veterans, or changes in weight and expenditures
attributable to MOVE!. It is important to understand longitudinal (20-year) patterns of VA healthcare
expenditures by BMI progression to characterize the long-run scope of the problem of obesity in VA. Such
results will then provide significant context for evaluating the health and economic effectiveness of MOVE!
participation. Taken together, the four specific aims will enable an examination of impact of MOVE! on Veteran
outcomes in the context of VA's overall population-level weight management strategy on eligible Veterans:
Aim 1: Identify latent classes of different BMI progression trajectories between 2000-2019.
Aim 2: Estimate differences in long term VA expenditures between latent BMI classes.
Aim 3: Identify the average treatment effect of MOVE! and characteristics of Veterans who experience the
greatest weight reductions following MOVE! participation.
Aim 4: Identify the average treatment effect of MOVE! on expenditures and characteristics of Veterans who
experience the greatest reduction in VA expenditures following MOVE! participation.
Next Steps: The examination of 20-year expenditures associated with obesity and differential effects of
MOVE! responds to one of the top four strategic goals identified in the VA FY 2018-2024 Strategic Plan by
informing approaches to focus resources more efficiently. This study also addresses HSR&D's cross-cutting
priority of business case and policy analysis and the Healthcare Informatics priority through the analysis,
validation, and application of Big Data sources to improve individual and population health. This research will
also enable us to formalize an algorithm to identify patients most likely to benefit from MOVE!, as well as those
unlikely to achieve significant clinical weight loss through MOVE!. Following identification of Veterans at
greatest risk for obesity and high VA expenditures, and of Veterans who experience the greatest weight and
expenditure improvements following weight loss intervention, we will partner with NCP to determine how best
to implement a prioritization strategy to develop need-tailored behavioral programs.

Public health relevance
About 68% of Veterans are considered either overweight or obese, which puts them at increased risk for hypertension, type 2 diabetes mellitus, coronary heart disease, and osteoarthritis. These clinical risks lead obese patients to incur disproportionately high health expenditures. No prior VA studies have examined the natural history of weight gain, long-term expenditures of normal weight, overweight and obese Veterans, or changes in weight and expenditures attributable to MOVE!. We propose to examine 20-year patterns of VA weight and VA expenditures for Veterans to characterize the long-run scope of the health and economic impacts of obesity in VA. Results on these long-term trends will then provide significant context for our proposed evaluation of the clinical and economic impacts of MOVE! participation and identification of specific Veterans subgroups that experience above-average benefits from MOVE!